Neuropathology Core

The overarching goal of the ADNI Neuropathology Core (NPC) is to support the discovery and validation
of antemortem biomarkers for Alzheimer disease and related dementias (ADRD). To achieve that goal, the NPC
performs uniform comprehensive neuropathologic examinations for ADNI participants, allowing clinical
diagnoses, fluid biomarker results, and neuroimaging data to be compared to ‘gold-standard’ neuropathologic
findings; the NPC also curates ADNI brain tissue specimens to facilitate ADNI and non-ADNI biomarker research.
For ADNI4, the NPC will: 1) encourage, collect, process, and store participant brain donations from all
ADNI sites for present and future ADRD biomarker studies; 2) provide a uniform neuropathologic assessment of
all brain donations; 3) use neuropathologic data from the ADNI cohort to validate clinical diagnoses and AD
biomarkers used for enrollment and outcome measures in clinical trials; 4) facilitate the use of ADNI participant
brain tissue in biomarker research; 5) develop culturally appropriate strategies to encourage brain donation by
all participants, including under-represented groups; and 6) investigate possible neuropathologic disparities in
under-represented groups, when suitable cases become available, in support of the ADNI4 diversity initiative.
The NPC has very successfully promoted brain donation at ADNI sites in preparation for ADNI4. With
support from two NIA administrative supplements, the NPC has: hired a full-time ADNI NPC coordinator; formally
surveyed ADNI sites to identify obstacles to brain donation; established an award program to overcome these
obstacles; helped 6 sites start new brain donation programs; introduced protocol changes allowing lapsed ADNI2
participants to re-enroll for ‘brain donation only’ and allowing more frequent monitoring of autopsy-consented
participants to update donation logistics; and begun to ‘retrieve’ 49 ADNI participant brain donations from ADNI-
affiliated ADCs for uniform re-assessment and inclusion in the ADNI NPC Tissue Resource. The ADNI NPC
Cohort, now n=133, is expected to grow by approximately 40 per year of ADNI4.
Growth of the NPC cohort will be critical for the mission of ADNI4. Clinicopathologic review of the first 84
ADNI brain donations reveals that: only 84% of participants clinically diagnosed with AD dementia (ADD) had
sufficient AD neuropathology (ADNC) to account for dementia; only 60% of participants diagnosed with ADD
plus another contributing disease showed sufficient ADNC; and 57% of participants who received a non-ADD
diagnosis actually harbored ‘low’ or ‘intermediate’ ADNC. Additionally, among participants with sufficient ADNC,
82% also showed neuropathologic co-morbidities with potential to influence cognition and/or biomarker data.
These data suggest that: evaluations of biomarkers based on clinical diagnosis may be inaccurate; AD clinical
trials relying solely on clinical diagnosis are likely to enroll some patients who do not suffer from AD; and clinical
trials that do employ AD biomarkers will still include patients with non-AD co-pathologies that contribute to
dementia. Clearly, maximizing neuropathologic evaluations will be critical for mission success in ADNI4.